Perfusion-based renal allograft modification to attenuate ischemia/reperfusion injury

Project Summary/Abstract
Perfusion-based renal allograft modification to attenuate ischemia/reperfusion injury
Reducing the timing and dose of systemic immunosuppression in transplant patients is an important clinical need.
Pre-transplant ex vivo organ perfusion provides a unique opportunity for the chemical modification of allograft
surfaces to facilitate engraftment and reduce inflammation and immunogenicity following transplantation. In our
published and preliminary studies, we have used covalent modifications to deliver potent therapeutics to donor
graft in murine islet and renal transplant models. Additionally, recent preliminary data supports that the covalent
modification of renal tissue by ex vivo perfusion is well-tolerated (with no adverse impact on renal function
observed) and durable (with intact modifications observed at 35 days post-transplant). The long-term objective of
this research is to test the potency and safety of this novel strategy for localized drug delivery in transplantation.
The proposed studies will explore the preparation and targeted and sustained delivery of an integrin inhibitor,
immobilized via pre-transplant ex vivo perfusion, in a well-characterized murine model of kidney transplantation.
We hypothesize that covalent kidney graft modification with a releasable small molecule integrin inhibitor prior
to transplantation will decrease immune cell recruitment to the graft after reperfusion. The ameliorated tissue
damage and donor antigen release will translate into reduced anti-donor adaptive immune responses and
improved transplant outcome without impairing systemic protective immunity.
Specific Aim 1. To test the efficacy and safety of renal graft modification with small molecule integrin inhibitor
for the modulation of ischemia reperfusion injury and the improvement of transplant survival and function.
This will be achieved in following steps:
1.a. To evaluate drug delivery by, and in vivo effects of, the ex vivo covalent modification of renal tissue.
1.b. To determine the effects of renal graft chemical modification with small molecule LFA-1 inhibitors on
the extent of ischemia/reperfusion injury (IRI) and subsequent local and systemic alloimmune
responses.
1.c. To test the effects of local vs systemic LFA-1 inhibition on protective immune responses.
1.d. To test the efficacy of donor graft chemical modification with LFA-1 inhibitor in prolonging renal
allograft survival in sensitized recipients.
1.e. To use the results from experiments in 1.a-d to further optimize the strategy for renal graft
modification with small molecule integrin inhibitors.
This high-risk, high-reward application will establish the proof of principle for pretransplant donor graft chemical
modification and localized integrin inhibition and will provide a foundation for future mechanistic experiments and
translational studies using large animal and human organs.

Public health relevance
Project Narrative Perfusion-based renal allograft modification to attenuate ischemia/reperfusion injury The proposed R21 project is focused on the development of targeted therapies for transplantation that decrease immune cell recruitment to the graft after reperfusion, limiting tissue damage and donor antigen release and reducing anti-donor adaptive immune responses and improving transplant outcomes while reducing systemic immunosuppression. We have verified that potent therapeutics can be safely and effectively delivered in islet and solid organ transplantation models using a combination of bioconjugation and prodrug strategies, and have demonstrated drug-eluting renal allografts that exhibit reduced innate inflammation. We now propose to use this graft-localized drug targeting strategy to deliver a potent LFA-1 inhibitor in a manner that addresses deficiencies inherent in these promising therapeutics (solubility/biodistribution issues and adverse systemic immunosuppression) in a well-characterized murine model of kidney transplantation, thereby providing a thorough and clinically relevant characterization of the safety of renal tissue modification and of the benefits of localized LFA-1 inhibition.